Functional differentiation of dorsal and ventral hippocampal place cell populations

Project Summary/Abstract. In the rat hippocampus (HPC), memories are thought to be coded by coordinated
sequences of “place cells”, neurons with receptive fields in specific spatial locations. During active behaviors,
place cells representing successive locations within learned trajectories fire as organized sequences within
cycles of the theta rhythm (~8 Hz). Place cell sequences that fire during active exploratory behaviors later
reactivate or “replay” in a temporally compressed manner during awake rest and slow-wave sleep. Replay is
thought to play a key role in memory consolidation and retrieval by transferring a compressed memory format
from the HPC to downstream cortical regions that control memory-guided behaviors. Theta-coordinated place
cell sequences and replay are widely believed to be important neuronal population mechanisms underlying HPC
memory encoding, consolidation, and retrieval. Yet, prior studies of theta-coordinated place cell sequences and
replay have focused on spatial memory operations in the dorsal HPC (dHPC). Whether coordinated place cell
sequences emerge in populations of ventral HPC (vHPC) place cells remains an open question. It is also
unknown whether vHPC place cell sequence replay occurs during sleep and rest. Moreover, the extent to which
coordinated place cell populations in dHPC and vHPC integrate unchanging non-spatial information, such as
emotional or motivational context, across different spatial locations remains largely unexplored. This project will
address these critical gaps in knowledge by testing two overarching hypotheses. The first hypothesis emerges
from prior studies of individual place cells and posits that coordinated place cell sequences in both dHPC and
vHPC code specific spatial trajectories at different spatial scales. An alternate hypothesis is that coordinated
sequences of dHPC place cells code specific spatial locations whereas vHPC place cell populations integrate
shared motivational and emotional contexts across different spatial locations. The proposed experiments
combine state-of-the-art neurophysiological methods for recording dHPC and vHPC place cell populations in
freely behaving rats with sophisticated analytical methods for decoding place cell sequence representations.
Experiments in Aim 1 will determine whether theta-coordinated sequences of place cells code longer trajectories
in vHPC than in dHPC. Aim 1 will also test whether vHPC, but not dHPC, place cell populations integrate shared
motivational or emotional information across different locations. Experiments in Aim 2 will test whether
sequences of place cells replay representations of longer trajectories in vHPC than in dHPC. Aim 2 will also test
the novel hypothesis that vHPC replay integrates representations of different spatial locations that share the
same emotional or motivational context, while dHPC replay separates representations of different spatial
locations that share the same nonspatial context. Results from this project will reveal whether dHPC and vHPC
place cell populations differentially encode, consolidate, and retrieve spatial and nonspatial components of
memories. Results will thereby produce a more comprehensive understanding of HPC mechanisms and function.

Public health relevance
Project Narrative. The hippocampus is a brain region that is critically involved in episodic memory but has also been linked to emotional and motivation-related functions. Understanding how the hippocampus carries out these seemingly disparate functions is critical for understanding how hippocampal dysfunction contributes to various mental health conditions. This proposal aims to study neurophysiological mechanisms of the hippocampus across distinct regions of its longitudinal axis to yield a comprehensive understanding of hippocampal function.